Proteomics and model organism humanization to decode human genetics

Summary/Abstract
While the human genome provides a parts list of >20,000 proteins, it is still largely unknown how these
proteins assemble into ‘molecular machines’ to carry out their biological roles. This is important both for basic
characterization of human genes and for understanding the mechanisms underlying most human genetic
diseases, which often arise from defects in systems of proteins working together. We focus on the >9,000 human
proteins shared across eukaryotes and dating to the last eukaryotic common ancestor. These ancient proteins
carry out critical cellular processes, including DNA replication, repair, transcription, splicing, mitochondrial and
ciliary processes, and trafficking, among others. They are disproportionately drivers of human disease, linked to
a wide array of disorders, spanning cancers, birth defects, metabolic disorders, Parkinson disease, Huntington
disease, amyotrophic lateral sclerosis, and more. Nearly 1,300 of these deeply conserved human proteins are
still mostly uncharacterized, despite almost certainly having important cell roles. A fundamental question is how
all of these proteins work together to support cell function. However, a key limitation remains the lack of large-
scale data directly interrogating these proteins’ expression, interactions, and activation states. Current
approaches to quantify the proteome are only beginning to survey the proteins in mammalian cells to any
significant depth, and consistently suffer from low sensitivity and throughput. These limitations have slowed
medical applications, e.g. biomarker discovery, where techniques including mass spectrometry and antibody
arrays often lack sufficient sensitivity and quantification accuracy to be effective. We propose research in three
broad areas: First, we propose a major effort to biochemically define the main human protein complexes,
providing a mechanistic basis for interpreting diverse human genetics and diseases. We will focus on
evolutionarily conserved human proteins due to these proteins’ critical importance to cellular function, leveraging
studies in other species using a comparative proteomics approach. Second, we are developing surrogate
functional assays for deeply conserved human proteins by systematically humanizing yeast cells, replacing each
essential yeast gene in turn by its human version. The resulting strains serve as new physical reagents for
studying human genes in a simplified organismal context, opening up simple high-throughput assays of human
gene function, the impact of human genetic variation on gene function, the screening and repurposing of drugs,
and the rapid determination of mechanisms of drug resistance. Finally, we aim to advance new proteomics
technologies, single-molecule protein sequencing and shotgun electron microscopy, both of which enable new
types of highly sensitive characterization of protein expression and physical organization relevant to many
aspects of human cell biology and disease. Success of these aims will give new insights into basic human cell
biology and biochemistry, laying the foundation for future attempts to intervene, chemically or genetically, with
those macromolecules most critical to the functioning of cells.

Public health relevance
Project Narrative Deeply conserved human genes are strongly linked to diverse diseases, from cancer to neurodegeneration to cardiovascular disease. We propose to study these critical human genes by (1) using a comparative proteomics approach to biochemically define how the encoded proteins physically organize into multiprotein assemblies, which will help us better understand a variety of human genetic diseases, (2) systematically replacing yeast genes with their human equivalents, using the humanized yeast to directly experimentally measure the effects of human genetic variation and gene-drug interactions, and (3) advancing new proteomics technologies that would have broad applications across biology and medicine. Success of these efforts will provide new insights into basic human cell biology and biochemistry, laying the foundation for future attempts to intervene, chemically or genetically, with proteins critical to human cell health and disease.